Data Acquisition and Analysis Core

Project Summary/Abstract
The ongoing goal of the Autism Biomarkers Consortium for Clinical Trials (ABC-CT) is to establish
electroencephalography (EEG) and eye-tracking (ET) biomarkers that can be used for stratification and/or as
sensitive and reliable objective assays related to social function in autism spectrum disorder (ASD) clinical trials.
This renewal application seeks to further validate promising measures through three studies designed to
enhance and extend the original ABC-CT study: (1) a confirmation study of the original findings in a new cohort
using similar design (T1: Baseline, T2: 6 weeks post baseline, T3: 24 weeks post baseline) and sample
size/characteristics (200 with ASD, 200 with typical development (TD)); (2) a follow-up study of the original cohort
(N=399) to re-administer the biomarker and clinical batteries 2.5-4 years after original ABC-CT enrollment; (3) a
feasibility study of parallel EEG and ET biomarkers in preschool-aged (3-5-year-old) children (25 with ASD, 25
with TD). The biomarker and clinical batteries measure key facets of social-communication in ASD using well-
validated paradigms appropriate for the intended developmental and cognitive range. The study will rely on the
same leadership and five Collaborating Implementation Sites (“Sites”) from the first phase, all highly experienced
in multi-site collaborative clinical research using the proposed clinical, EEG, and ET methodologies. The Data
Coordinating Core (DCC) will provide a secure informatics infrastructure for communication and data integration
across the consortium to ensure organized data management, quality control, and reliable upload to the National
Database for Autism Research (NDAR) and NIH Data Repositories. The Administrative Core, in coordination
with federal partners in this cooperative agreement, will oversee the operations of the sites, DCC, and Data
Acquisition and Analysis Core (DAAC) to ensure methodologically and ethically rigorous, efficient completion of
scientific aims. Across all studies, the DAAC will (1) refine and implement the protocols for acquisition and quality
control of EEG and ET measures; (2) update and implement rigorous, scientifically valid, and replicable data
processing pipelines for EEG and ET biomarker protocols; and (3) implement statistical analyses, provide broad-
based statistical consulting services, and spearhead novel methodological development. The DAAC relies upon
the team of scientific contributors involved in the first phase and active in collaborative ET, EEG, and statistical
methodology development, who are dedicated to the goals of the consortium. DAAC faculty and staff have been
selected for specific and unique expertise germane to this project and will put that knowledge toward their specific
roles in training, acquisition, processing, and analytics. Productive data flow will be obtained through operations
management including facilitating site acquisition, DCC data storage and monitoring, and establishing a clear
timeline for DAAC deliverables.